ACHIEVING BETTER CANCER DIAGNOSIS (ABCD): Identifying, supporting, and learning from marginalized patients who experience delayed cancer diagnosis

Delays in the diagnosis of cancer are too common. For patients diagnosed with advanced stage cancers, particularly
those with symptoms or findings that may represent missed opportunities for earlier diagnosis, this can be devastating.
These concerns are complicated by the nonspecific nature of cancer symptoms, hindsight bias, controversies around
over-diagnosis and over-testing, and now delays in screening and care due to COVID. Some patients experiencing a
delayed diagnosis may face additional challenges resulting from social determinants of health, racism, language barriers,
or inadequate health insurance. Prior studies examined system factors associated with delayed cancer diagnosis, but
progress on reducing these delays has been elusive. The patient voice has been missing, even though it is likely the one
voice with the most to say about how the delay occurred and opportunities for improvement. In our prior work, we
learned patients are frequently aware of problems in their care but hesitate to speak up for fear that it might adversely
affect their care. Silence around the delayed cancer diagnosis extends to all members of the healthcare team, given the
fear of malpractice litigation and the ingrained resistance to addressing problems in care transparently. We propose a
Diagnostic Center of Excellence (DCE) that will seek out and transparently address cases and causes of delayed diagnosis
of cancer by bringing together national experts on diagnostic safety (Brigham and Women’s Hospital/Harvard Medical
School) and on Communication and Resolution Programs, or CRPs (University of Washington). CRPs are systematic
processes for responding to problems in healthcare with transparency, accountability and learning. The project will
target delays and disparities for historically marginalized patients with breast, lung, colorectal, and prostate cancer, each
of which has recommended screening guidelines. The project encompasses the following specific aims: Specific Aim 1:
Create a DCE to design and implement a program to identify and learn from patients who experienced delays in
diagnosis of 4 leading cancers. We will partner with existing organizational resources and help to optimize them by
bringing together multiple streams of data to facilitate real-time identification of patients, particularly those from
marginalized populations, who may have experienced a delay in the diagnosis of cancer. Specific Aim 2: Engage and
learn from patients who have experienced delayed cancer diagnoses. We will identify 240 recently diagnosed cancer
patients at Dana Farber Cancer Institute and Fred Hutchinson Cancer Center. Using a novel patient advocate
intervention, we will conduct serial interviews to develop trust and learn about potential missed opportunities for
earlier diagnosis. We will then analyze these cases for improvement opportunities using existing validated tools. Specific
Aim 3. Implement and evaluate generalizable interventions to improve the cancer diagnostic process. Our Advisory
Committee will review ideas to improve cancer diagnosis emanating from Aims 1 and 2. We will test promising system
solutions using plan-do-study-act (PDSA) cycles. We will develop a robust, multifaceted Improving Cancer Diagnosis
Communication Toolkit designed for dissemination. By engaging patients and families who have a front row seat to the
full diagnostic process, we will harness novel insights to improve timely diagnosis of cancer.

Public health relevance
AHRQ Project summary Our Diagnostic Center of Excellence (DCE) will focus on detecting in real time patients with delayed diagnosis of cancer especially among marginalized patients, and then learning deeply from them about what went wrong, how delays could be avoided, and strategies to mitigate any harm that has occurred. This DCE will integrate extensive expertise on safety science, diagnosis improvement, and Communication and Resolution Programs (initiatives to detect and empathically respond to harm events). These insights from patients who have experienced delayed cancer diagnosis about what happened and how we can improve are at present largely missing but are essential if meaningful reductions in delayed diagnoses are to occur.